Genetic determinants of "innate" T lymphocytes development and homeostasis

Project Summary Innate conventional their requirement namely, molecules, the uncertain. systems, polymorphism mapping resources development a variation using T cells are a heterogeneous group of ?? and ?? T cells that respond much more r apidly than T cells upon activation. This swiftness of response r eflects their acquisition of functionality during development in the thymus. These innate T cells also share a non-MHC class I or II restriction for antigen recognition. Three major populations within the innate T cell group are recognized, the invariant NKT cells that recognize glycolipid antigens presented by non-polymorphic CD1d the mucosal associated invariant T (MAIT) cells t hat recognize vitamin metabolites presented by non-polymorphic MR1 molecules, and the gamma delta T cells which antigen specificities remain Altogether, these innate T cells, acting as bridges between the innate and adaptive immune contribute greatly to immune regulation and host protection. To appreciate the role that host play in steady-state evelopment and homeostasis of innate T cells, we propose to use QTL in the Collaborative Cross and Diversity Outbred (DO) mice. These genetically diverse mouse provide powerful experimental systems to test the ypothesis that variation in innate T cell and homeostasis is genetically regulated and to map the source of the diversity. We will conduct comprehensive screen of CC and DO strains for innate T cells to estimate the diversity resulting from genetic (Aim 1). We will then identify genes that underlie variation in innate T cell development/homeostasis QTL mapping (Aim 2). d h Given their capacity to link key inflammatory axes of innate and adaptive immunity, a better understanding of the molecular basis underpinning innate T cell development and plasticity, and how much this feature accounts for their pathophysiological roles, is critical for developing novel therapeutic approaches.

Public health relevance
Project Narrative The proposed studies aim to as homeostasis use genetically diverse mouse resources, such as the Collaborative Cross mice, powerful experimental systems to test the hypothesis that variation in innate T cell development and is genetically regulated and to map the source of the diversity.These studies will open up substantial new possibilities for understanding innate T cells development and effector programming so that it can be exploited for therapeutic usage to improve human health.